TranExamic Atomized for Pediatric post-Operative Tonsillectomy hemorrhage (TEAPOT)

PROJECT SUMMARY/ABSTRACT
Tonsillectomy is the second most common pediatric surgical procedure in the United States, with more than
530,000 performed annually. Regrettably, 4-5% of these children experience a post-tonsillectomy hemorrhage
(PTH) leading to emergency departments (ED) visits, hospital readmissions, blood transfusions, and surgical
interventions. Conventional interventions are limited, as the bleeding is often difficult to visualize and access,
making direct pressure or medication application impractical. Currently, more than 60% of otolaryngologists
(ENTs) choose a second surgery for examination under general anesthesia and cauterization to control PTH
bleeding. A second surgical intervention increases morbidity due to local trauma from securing a bleeding airway,
anesthesia medications that may have neurotoxic effects, and additional pain resulting from the repeat
cauterization of the tonsillar bed. Our preliminary data demonstrated that three doses of nebulized tranexamic
acid (TXA) delivered to children with PTH reduces the need for a second operation by 44% with no safety
concerns. Compared to earlier reports and studies, nebulized TXA is the first non-operative intervention that
successfully decreased the need for an invasive procedure to control upper airway bleeding in children with PTH.
We also found that jet nebulized TXA at 15 L/min delivers appropriately sized particles to mostly deposit at the
tonsil bed. Our overall hypothesis is that nebulized TXA is a safe and easily administered treatment decreasing
the severity of bleeding and the need for repeat surgical intervention in children with PTH. In preparation for a
phase 3 trial, we will build on our preliminary data and investigational new drug (IND) approval to conduct a
multicenter, randomized controlled, blinded pilot trial. The objectives of the pilot trial will be to assess enrollment
feasibility, protocol adherence, and TXA absorption. Our research is highly significant, offering a novel and
scientifically promising intervention for a condition with substantial morbidity and a lack of effective bedside
treatments. Our approach innovative, as nebulized TXA has not been well studied in children, and we will develop
a pulmonary pharmacokinetic model for TXA that can be extrapolated to other bleeding conditions. The
anticipated impact of this pilot study is to generate feasibility and pharmacokinetic data, setting the stage for a
subsequent multicenter phase 3 clinical trial that will have the power to demonstrate the efficacy of nebulized
TXA in reducing the need for surgical interventions.

Public health relevance
Project Narrative The proposed research improves public health because post-tonsillectomy hemorrhage (PTH) is common post- operative complication affecting thousands of children in the United States every year. Over 60% of otolaryngologists will perform a second surgery to reduce the severity of PTH. Our pilot trial will establish the feasibility and protocol adherence for a randomized, placebo-controlled, blinded clinical trial to determine if nebulized tranexamic acid, a non-invasive therapy, can decrease the severity of PTH and prevent the need for a second surgery.